Novel automated performance-based ADL outcomes for early AD clinical trials

Project Summary
Impairment in activities of daily living (ADL) is a hallmark of Alzheimer’s disease (AD) dementia
and a major source of caregiver burden. Similar to cognitive and behavioral changes in AD, subtle
difficulties in complex ADL may begin even before the stage of amnestic mild cognitive
impairment (MCI). Preclinical AD consists of individuals with minimal or no symptoms but
biomarker evidence of AD pathology. As secondary prevention trials in preclinical AD are being
launched and the FDA is providing new guidance for early AD trial outcomes, it is imperative that
we develop new ecologically valid instruments to detect subtle yet clinically meaningful
alterations in complex ADL. Older individuals are increasingly required to interact via
telephone and computer-based technology to perform essential ADL. The overall goal of this
proposal is to optimize and validate a novel set of automated performance-based ADL instruments,
the Harvard Automated Phone Task (APT) and computer- based Czaja Functional Assessment
Battery (CFAB), which have been designed to tap the high level tasks that challenge seniors in
daily life and to serve as ADL outcomes for preclinical and early prodromal AD clinical trials. For
the first time, we have a chance to visualize regional tau deposition in vivo, using a new
promising positron emission tomography (PET) tracer, T807, a.k.a. 18F-AV-1451. 1) To
date, there have been no consistent associations between ADL performance and AD biomarkers in
clinically normal (CN) elderly or early MCI alone. 2) We now have a unique opportunity to relate
novel molecular imaging biomarkers of tau and amyloid to our novel ADL instruments. 3) There are no
established instruments for detecting early ADL changes in CN individuals who may be in the
preclinical stages of AD or in individuals with early prodromal AD. Here we seek
to fill this gap in knowledge by further validating the Harvard APT and CFAB.
The telephone is still the most prevalent technology mode of communication in the elderly, nearly
all of whom in North America own a phone; about a third own a computer; more are starting to use
smartphones; and most need to use an interactive voice response system (IVRS) to complete everyday
activities. In the Harvard APT, subjects navigate an IVRS in order to refill a prescription
(APT-Script), select a new physician (APT-PCP), and make a bank account transfer and payment
(APT-Bank). In the CFAB, subjects refill a prescription (CFAB-Script) and perform automated teller
machine (ATM) transactions (CFAB-ATM). These tasks simulate real-life activities commonly required
of elderly. We will assess the Harvard APT and CFAB in 200 subjects (100 CN, 50 subjective
cognitive decline (SCD), and 50 MCI), assess their relationship to cognitive function at baseline
and over 3 years, assess their ability to track disease progression, and assess their relationship
to AD imaging biomarkers. We will leverage a unique well-characterized sample from other funded
studies to recruit the 100 CN subjects, who will already have imaging data and will only need to
undergo the novel ADL tests. The 100 SCD and MCI subjects will be newly recruited and will undergo
both clinical and imaging assessments.

Public health relevance
The field is moving toward finding more sensitive clinical measures for early diagnosis that are associated with AD biomarkers but are easy and inexpensive to administer by primary care physicians, who are on the frontlines of the medical battle. The challenge is to detect the earliest changes in everyday activities that portend the cognitive and behavioral deficits in AD that relentlessly impair the lives of patients and caregivers. Developing more sensitive, ecologically valid performance-based ADL instruments, like the Harvard APT and CFAB, is vital to the goal of improving detection of preclinical AD and identifying individuals at the tipping point between preclinical and early prodromal AD, as well as serving as clinically meaningful outcomes in early AD clinical trials as we strive toward finding the earliest disease modifying treatments.